Chemoproteomics and Lipidomics for Identifying Dysregulated Enzymes and Lipids in Cutaneous Disorders.

PROJECT SUMMARY
This project aims to advance the treatment of atopic dermatitis (AD) by identifying novel drug targets through an
innovative chemical biology platform, Profiling of Active Cutaneous Enzymes (PACE), in conjunction with
untargeted lipidomics. AD is characterized by skin barrier dysfunction and chronic inflammation, with lipids
playing a central role in maintaining skin structure and modulating immune responses. Despite their importance,
the role of lipids and lipid-regulating enzymes in AD and other skin diseases is often underappreciated due to
the limitations of traditional methods for analyzing proteins and enzymes in the skin. The primary objective of
this proposal is to overcome these challenges by developing the PACE platform to investigate enzyme regulation
and lipid metabolism in AD. The study will begin with the identification of dysregulated enzymes and lipid
alterations in human AD skin using activity-based protein profiling (ABPP) and lipidomics. These candidate
enzymes will then undergo functional validation in preclinical AD models, where their expression will be
modulated to assess their impact on lipid profiles, biochemical markers, and histological and clinical outcomes.
Finally, the project will screen for selective inhibitors targeting these functionally validated enzymes, with the
goal of developing new therapeutic strategies for AD. The expected outcomes include an enhanced
understanding of the role of lipids and enzymes in skin health and disease, the identification of novel therapeutic
targets, and the potential for applying this platform to other cutaneous diseases. This research aligns with the
broader goals of improving treatments for skin conditions by addressing the underlying biochemical mechanisms.

Public health relevance
PROJECT NARRATIVE This project aims to advance the treatment of atopic dermatitis (AD) by identifying novel drug targets using the innovative chemoproteomics platform, Profiling of Active Cutaneous Enzymes (PACE), in combination with global lipidomics. By analyzing skin samples from both human patients and pre-clinical animal models, we will discover dysregulated enzymes and develop selective inhibitors, leading to new therapeutic strategies. The expected outcomes include a deeper understanding of skin lipids and enzymes in health and disease, the identification of new therapeutic targets, and the potential for applying this platform to other skin diseases.